Validation and Early Commercialization of the ENVISAGE Assay, a Prognostic Test for Barrett's Esophagus

Barrett’s esophagus (BE) is the strongest known risk factor for, and obligate precursor of, esophageal high-
grade dysplasia (HGD) and adenocarcinoma (EAC). However, determining future neoplastic progression risk
is quite challenging in BE patients: current risk estimation is based solely on highly variable, subjective,
observer-dependent histopathologic diagnoses (i.e., non-dysplastic (ND), Low-Grade Dysplasia (LGD),
Indeterminate for Dysplasia (IFD), or High-Grade Dysplasia (HGD). Our ENVISAGE assay is a validated
(CLIA # 21D2256153) laboratory-developed test (LDT) based on a 4-gene-plus-patient age DNA
methylation-based PCR assay that was developed at Capsulomics built on foundational studies performed
at Johns Hopkins University (JHU). Our preliminary studies yielded a ready-to-launch 1st-generation assay
that accurately predicts the risk of future neoplastic progression in BE patients based on levels of molecular
biomarkers. This prognostic assay risk-stratifies patients to vastly improve clinical decision-making, with a
sensitivity of 71% and a specificity of 90%, outperforming any other clinically available tests.
Notwithstanding this early success, we have identified a need for further improvement as well as a robust
commercialization pathway. With funding of this direct-to-phase II proposal, we will make significant
improvements to generate a more sensitive, more robustly validated second-generation product, while
building a foundation for strategic commercialization and market adoption of both the current and future
assays. Aim 1 will address assay sensitivity challenges due to using limited-quantity, low-quality fragmented
DNA from biopsy specimens by engineering a new assay based on multiplex PCR. This advancement will
also improve throughput, efficiency, cost, and processing speed. Aims 2 and 3 will augment our study
population while incorporating the new multiplex protocol from Aim 1, retain and refine our algorithm to
produce a 2nd-generation ENVISAGE assay, and more sharply delineate which patients will fall into the
“Intermediate” risk category for improved clinical management. Aim 4 will establish early commercialization
of the 1st-generation assay as an LDT while developing a platform for the future launch of our 2nd-generation
product. Thus, this direct-to-phase II SBIR proposal will expand, refine, and validate the ENVISAGE assay,
a novel LDT for stratifying future neoplastic progression risk in BE patients, thereby improving clinical
decision-making.

Public health relevance
Our team has an established history of invention, development, optimization, and validation of a ready-to-launch lab-developed test (LDT), the ENVISAGE assay. This epigenetic biomarker assay predicts future progression risk in patients with Barrett’s esophagus, with 71% sensitivity and 90% specificity. This strong performance for a prognostic assay surpasses any clinical assay currently available. Successful refinement and validation of our proposed 2nd-generation assay will greatly enhance the current repertoire of clinical tools for more precise, efficient, and accurate patient care.